Animal cathlab C-arm

In this S10 application, we request budget for replacing cathlab system in the Center for
Comparative Medicine and Surgery (CCMS) at the Icahn School of Medicine at Mount Sinai
(ISMMS). The Cardiovascular Laboratory for Translational Research (CLTR) supported by both
Cardiovascular Research Institute and CCMS has been pioneering clinical translation of novel
therapeutic approaches. The cathlab system that offered high-throughput, low-mortality
experiments in large animals have aged, and C-arm is at end of its equipment life.
In order to continue highly active translational cardiovascular research, we propose to
replace existing system with state-of-art equipment. The requested items include C-arm and its
accessories for cath lab procedures. Despite being smaller than current ceiling-mounted C-arm,
image quality will improve significantly due to the technical advances. Moreover, radiation
exposure will be substantially reduced and offers safer experiments to investigators and animals.
The mobile function also offers imaging during surgery, which was not available in our institution
during the past several years.
Higher imaging quality will offer improved assessments of cardiovascular morphology
and function. The new equipment will lead to improved animal monitoring and reduced
measurement variability, which can reduce the number of animals required for each experiment.
The new cathlab system will continue to assist translational work of current users, while offering
new opportunities to all Mount Sinai investigators with translational interest.

Public health relevance
To continue highly active translational cardiovascular research at the Icahn School of Medicine at Sinai, new cathlab system is essential. New mobile C-arm that is requested in this application will improve image quality, offer additional procedures, and reduce radiation exposure of animals and investigators.